Ceramide-induced cell death in neurodegeneration

DESCRIPTION (provided by applicant): Alzheimer's disease (AD) is characterized by the progressive loss of neurons in the hippocampus ultimately leading to total memory loss and death of the patient. Neuronal cell death is thought to be caused by the build-up of protein-aggregates termed plaques and tangles. The role of astrocytes in neuronal cell death is only marginally understood. Most recently, we have found that astrocytes from a mouse model of AD (PS1M146V) express 9-fold higher levels of prostate apoptosis response-4 (PAR-4) than wild-type astrocytes. PAR-4 is a pro-apoptotic protein that inhibits atypical PKC6/; (aPKC) when associated with ceramide. Our main hypothesis is that elevation of PAR-4 sensitizes astrocytes toward ceramide-induced apoptosis, which leads to neurodegeneration in AD. Very exciting new results show that hippocampal tissue from the PS1 mouse is enriched in distinct ceramide species that induce apoptosis in PS1 astrocytes, but not in wild-type cells. This result clearly demonstrates that PS1 astrocytes are specifically sensitive to ceramide elevation. Further, in hippocampus from AD patients, amyloid plaques are surrounded by astrocytes that show co-elevation of ceramide and PAR-4. Many of these astrocytes are apoptotic. We will now determine how ceramide elevation is activated (Specific Aim 1), how the combined elevation of ceramide and PAR-4 induces apoptosis (Specific Aim 2), and how this co-elevation elevation and apoptosis induction can be prevented (Specific Aim 3). SIGNIFICANCE: We have shown for the first time that astrocytes from AD brain are specifically eliminated by ceramide-induced apoptosis. Using a combination of in vitro and in vivo models (Psen1 and APP/PS1 astrocytes and mice); our study will develop a novel strategy to protect astrocytes and neurons from apoptosis. This strategy will be highly significant for treatment of AD

Public health relevance
PUBLIC HEALTH RELEVANCE: Alzheimer's disease (AD) is a devastating disease affecting 5 million people in the United States. Progressive memory loss and ultimately, cell death of neurons is caused by the build-up of protein aggregates called "plaques" and "tangles". We have found, for the first time, that in a mouse model of AD, the lipid ceramide is enriched and specifically induces cell death in astrocytes. We hypothesize that dying astrocytes fail to support neurons, which amplifies the degeneration of neurons in AD. Our data strongly suggest that blocking the accumulation of ceramide will be instrumental in preventing loss of neurons in AD. Alzheimer's disease (AD) is a devastating disease affecting 5 million people in the United States. Progressive memory loss and ultimately, cell death of neurons is caused by the build-up of protein aggregates called "plaques" and "tangles". We have found, for the first time, that in a mouse model of AD, the lipid ceramide is enriched and specifically induces cell death in astrocytes. We hypothesize that dying astroctyes fail to support neurons, which amplifies the degeneration of neurons in AD. Our data strongly suggest that blocking the accumulation of ceramide will be instrumental in preventing loss of neurons in AD. __SpecificAimsTextDelimiter__ Program Director/Principal Investigator (Last, First, Middle): Bieberich, Erhard A. SPECIFIC AIMS Summary: Alzheimer's disease (AD) is characterized by the progressive loss of neurons in the hippocampus, ultimately leading to total memory loss and death of the patient. Neuronal cell death is thought to be caused by the build-up of protein-aggregates termed "plaques" and "tangles". The role of astrocytes in neuronal cell death is only marginally understood. Most recently, we have found that astrocytes from a mouse model of AD (PS1M146V; PS1) express 9.5-fold higher levels of prostate apoptosis response-4 (PAR-4) than wild-type astrocytes. We have shown that PAR-4 is a pro-apoptotic protein that inhibits atypical PKCζ/λ (aPKC) when associated with ceramide. Therefore, PAR-4 sensitizes neural cells toward ceramide-induced apoptosis. We hypothesize that the combined elevation of PAR-4 and ceramide induces apoptosis in astrocytes, which leads to neurodegeneration in AD (Fig. 1). Very exciting new results show that hippocampal tissue from the PS1 mouse is enriched with distinct ceramide species that induce apoptosis in PS1 astrocytes, but not in wild-type cells. Our results clearly demonstrate that PS1 astrocytes are specifically sensitive to ceramide elevation. We will now determine how elevation of pro-apoptotic ceramide is activated (Specific Aim 1), how the combined elevation of ceramide and PAR-4 induces apoptosis (Specific Aim 2), and how this elevation and apoptosis induction can be prevented (Specific Aim 3). SIGNIFICANCE: We have shown for the first time that astrocytes from a PS1 mouse model are specifically eliminated by ceramide-induced apoptosis. Using a combination of in vitro and in vivo models (PS1 and APP/PS1 astrocytes and mice); our study will develop a novel strategy to protect astrocytes and neurons from apoptosis. Therefore, it is of immediate translational value for treatment of AD. Figure 1 SPECIFIC AIM 1: To test the hypothesis that pro-apoptotic ceramide is elevated by Aβ or cytokine- mediated activation of astrocytes. We have shown that pro-apoptotic ceramide is elevated in PS1 brain. We propose that Aβ and neuroinflammatory cytokines trigger ceramide elevation in astrocytes. To understand how ceramide contributes to AD, it is crucial to determine where, which, and how ceramide is elevated. Subaim 1: We will determine which pro-apoptotic ceramide species are elevated in astrocytes in vitro and in vivo, with and without Aβ or cytokine activation using wild-type, PS1 and APP/PS1 mouse models. We will also analyze the composition and distribution of ceramide in brain tissue from AD patients. Subaim 2: We will test if Aβ or cytokine activation stimulates specific ceramide synthases (e.g., lass 2, 4) and sphingomyelinase(s) (e.g., NSMase2) in vitro and in vivo, which leads to enrichment of pro-apoptotic ceramide. Our results will define a novel mechanism, by which Aβ accumulation and cytokines cause elevation of ceramide. This data is essential to define the role of ceramide elevation for astrocytic cell death in AD. SPECIFIC AIM 2: To test the hypothesis that the combined elevation of ceramide and PAR-4 induces apoptosis in astrocytes. We have reported that the combined elevation of ceramide and PAR-4 inactivates aPKC and Akt, thereby inducing apoptosis in differentiating stem cells. To understand apoptosis in AD, it is crucial to determine the role of PAR-4/aPKC and its downstream cell signaling pathways. Subaim 1: We will define the critical function of PAR-4 for apoptosis by knocking down or ectopically expressing PAR-4, thereby preventing or enhancing ceramide-induced apoptosis, respectively. Subaim 2: We will determine the activation of pro-survival or pro-death signaling pathways (Akt, Bcl-2, and Bax) after alteration of ceramide and PAR-4 expression in vitro, and during AD progression in vivo. Our results will define a novel mechanism, by which ceramide elevation in astrocytes inactivates cell survival signaling pathways. This data is the key to understand ceramide-induced cell death in AD. SPECIFIC AIM 3: To test the hypothesis that inhibition of ceramide elevation or re-activation of cell survival prevents astrocytic cell death, and alleviates AD in vivo. We have shown that in PS1 astrocytes, particular ceramide species induce apoptosis, while others are non-apoptotic. We anticipate that reduction of ceramide levels and re-activation of cell survival signaling pathways is instrumental to treat AD. Subaim 1: We will test if ceramide levels can be reduced or normalized by inhibition of de novo ceramide biosynthesis or sphingomyelin-derived ceramide generation in vitro and in vivo. Subaim 2: We will determine if non-apoptotic ceramide derivatives (e.g., S1P) or their analogs (e.g., FTY720) can re-activate aPKC or Akt and prevent ceramide-induced astrocytic cell death in vitro and in vivo. Our results will define a novel strategy utilizing alteration of sphingolipid metabolism and re-activation of cell survival signaling as a highly significant option to prevent astrocytic cell death, and treat AD. PHS 398/2590 (Rev. 11/07 Page 1 Continuation Format Page